Regulation and function of human neural circular RNAs

Project Summary
Circular RNAs (circRNAs) are a novel class of covalently closed RNA species derived from “back
splicing” of pre-mRNAs. Mounting evidence suggests the essential roles of circRNAs in governing
healthy brain development and their abnormalities in neurological and neuropsychiatric disorders.
Many circRNAs are unique and highly abundant in the human brain, which are thought to underlie the
sophisticated function of human brains and the fragility of various brain diseases. Mechanistically,
circRNAs can function through sponging microRNAs or RNA-binding proteins, which broadly regulate
numerous biological pathways. Our current knowledge of molecular mechanisms that regulate
circRNA biogenesis in the human brain is still in its infancy. In particular, circRNA biology in human
glial cells are poorly understood. Whether neurons and glia cells possess distinct circRNA landscapes
and downstream interactomes remain entirely unknown. The biological functions of circRNAs in
governing brain development and modulating lesion repair are vastly elusive. These prevailing
knowledge gaps limit the current understanding of the complex etiology of many brain diseases. Our
long-term goals are to elucidate the regulation and function of circRNAs in healthy and diseased
brains, which may help to develop novel therapeutics against brain illnesses. In this application, we
focus on circRNA biology in oligodendroglia (OL). OLs are responsible for myelination of the central
nervous system and affected in numerous diseases, represented by multiple sclerosis and
schizophrenia. Our preliminary data revealed that the RNA-binding protein QKI advances biogenesis
of a human OL circRNA, which can promote differentiation of human and rodent OLs. We established
state-of-the-art technical platforms to identify circRNA landscapes and interactomes in human OL and
neurons. We hypothesize that human circRNAs play essential roles in controlling OL and myelin
development, and QKI mediates developmental signals to enhance human OL circRNA biogenesis.
In Aim 1, we will determine how QKI regulates OL circRNA biogenesis to advance OL differentiation.
In Aim 2, we will determine developmental regulation of human OL circRNA landscapes, downstream
pathways, and mechanisms of circRNA action in OLs from multiple platforms with integrated
analyses. In Aim 3, we will explore whether human OL circRNA pathways can promote OL lineage
development in human induced pluripotent stem cell (iPSC)-derived oligodendrocyte spheres (hOLS)
or myelin lesion repair in a well-established mouse model. Findings from these studies will provide
novel insights on fundamental rules governing human OL function and myelin repair.

Public health relevance
Successful completion of the proposed studies will significantly advance our knowledge regarding molecular mechanisms that govern human oligodendroglia-specific circRNA landscapes and may identify human oligodendroglia circRNAs that promote myelin lesion repair, which will have a significant impact on myelin disorders. Given the increasingly documented circRNA abnormalities in neurodegenerative and neuropsychiatric diseases, strategies and experimental tools generated by our studies can be readily applied to explore circRNA function in various neural cell types in healthy and diseased human brains far beyond this proposal, which is a critical prerequisite for developing novel diagnosis/prognosis biomarkers and therapeutics.